Core 3: Population & Data Modeling

PROJECT SUMMARY: Population Data & Modeling Core (PDMC)
At this time, overdose deaths reduce US life expectancy and we are spending more than $500 billion per year
on treating substance use disorders and their medical consequences. Considering the wide spectrum of
clinical and economic consequences of substance use, the U. faces a “syndemic” of substance use disorder,
HIV, HCV, and bacterial infections. In response, we propose to replace the former HCV & HIV Core with a
Population Data & Modeling Core (PDMC) that has a broader mission to use secondary data and modeling to
address population outcomes of this syndemic. One powerful approach to measuring economic value is using
“big data” from the real world. Linked administrative records and data repositories from electronic health
records compliment traditional prospective study designs and are an essential tool for health economics
research. Administrative and clinical records are still more powerful when coupled to simulation models.
Simulation models can integrate the most up-to-date knowledge about the epidemiology and natural history of
substance use disorders, treatment outcomes, and resource utilization to make policy-relevant insights about
treatment and care. The overall aim of CHERISH (Center for Health Economics of Treatment Interventions for
Substance Use Disorder, HCV, and HIV) is to develop and disseminate economic evidence that informs
substance use disorder policy and HCV and HIV care of people who use substances. In this renewal period we
will expand our focus to outcome and implementation research that is conducted at the individual, system, and
community levels with the following specific aims: 1) to promote the use of population data from linked
administrative and clinical records in conducting community-level economic evaluations of treatment and care
for substance use disorder, and HCV and HIV among people who use substances, and 2) to advance the
application of simulation modeling methods to evaluations of the economic and population outcomes of
substance use disorder, HCV, and HIV treatment for people who use substances. We will also leverage our
unique expertise working with linked state-level administrative data across multiple state agencies in
Massachusetts to help establish best practices for building and using similar databases in other states. We will
collaborate with colleagues to create and sustain a network of researchers who employ simulation models to
inform the response to the opioid crisis. We will sponsor an annual working group meeting, publish
manuscripts identifying best practices for simulating substance use disorder and the transmission of HCV and
HIV among people who inject drugs, and work closely with the Dissemination & Policy Core to develop best
practices for translating simulation model outcomes into actionable policy messages.